A Comparison of Treatment Strategies for Recovery of Swallow and Swallow-Respiratory Coupling Following a Prolonged Liquid Diet in a Young Animal Model

Project Summary
Successful transition of healthy infants from breast- or bottle-feeding to textured foods requires the
development of complex neuromuscular control. This transition must also occur within the context of rapid
growth and development and increased nutritional demands. To initiate this process, complementary foods are
typically introduced by 4-6 months of age and continue throughout early childhood. Delaying the introduction of
complementary foods past 10 months of age places an otherwise healthy child at risk for persistent feeding
problems to develop well into the school-age years. This suggests that prolonged liquid diets fundamentally
alter feeding performance and the underlying oral and pharyngeal function and coordination. Currently,
however, limited data is available on precisely what rehabilitation strategy would be best to implement if this
critical window of oral sensorimotor development has passed. Our limited understanding is due, in part, to
human subject research protections in place for healthy infants and children when examining the swallow
during feeding and to their relatively slow growth rates which make longitudinal studies infeasible. The
proposed work will determine whether feeding performance and its underlying physiology and biomechanics
can be recovered following long-term use of a texture-modified diet during the critical periods of growth and
oral sensorimotor maturation in an animal model. This project will compare feeding and swallow-respiratory
coupling performance outcomes for animals reared on a texture-modified diet during early maturation and then
transitioned to textured foods using one of two rehabilitation strategies: direct transition or progressive
transition. The outcomes of these two rehabilitation strategies will be compared to normally-weaned age-
matched control animals (Specific Aim 1). This project will also examine the coordination of oral (jaw and
tongue) and hyolaryngeal movements and their motor control during feeding in each group (direct transition,
progressive transition, controls) (Specific Aim 2). Synchronized high speed biplanar fluoroscopy,
electromyography, and respiration data over 4 months in infant, juvenile, and subadult animals will provide
sequence- and cycle-level analyses across critical developmental stages. Results will enable us to tease apart
the relationship between growth and development, function, and performance as animals transition from a
liquid to a solid diet after critical windows of oral development have closed. This research is essential for
optimizing specific rehabilitation strategies for healthy infants who struggle to accept complementary foods.
This research also lays the groundwork for treating other populations such as healthy preterm infants and
children who present with underlying conditions affecting oropharyngeal coordination that complicate weaning
and the successful transition to solid foods.

Public health relevance
Project Narrative Otherwise healthy children who have been introduced to complementary foods outside of a critical developmental window can develop structural abnormalities of the orofacial region and aberrant chewing behaviors. While a sustained liquid diet can safely provide nutrition to these children, how to best remediate and safely facilitate maturation of their chewing patterns is not known. This project will test two treatment strategies on the recovery of oral function in an animal model to guide clinical decisions about feeding rehabilitation in healthy children and lay the groundwork for clinical decision-making for healthy preterm infants and children with underlying physical and/or neurological disabilities that delay the acquisition of oral skills.